Assessing the Relative and Absolute Risk for site-Specific Cancer Mortality attributed to Household Air Pollution

Household air pollution (HAP) attributed to wood use is a potential environmental risk factor for lung cancer, to
which ~2.5 billion people worldwide (including >15 million in the US) are exposed. Known lung cancer risk factors
(i.e., environmental tobacco smoke (ETS), outdoor air pollution (OAP), family history) do not fully account for the
disease burden. To reach robust conclusions about biomass's pulmonary carcinogenicity and the lung cancer deaths
attributed to HAP while accounting for confounding exposures, prospective studies of individuals experiencing a
variety of exposure levels of HAP, ETS, and other suspected lung carcinogens are needed. We will leverage our
global consortium of prospective studies (HAPCO: Household Air Pollution Cohorts), which is a pooled resource
of >550,000 subjects, to for the first time accurately quantify the relative risk of lung cancer mortality associated
with wood use. Further, we will estimate time-dependent population-attributable fraction (PAF) function for lung
cancer mortality, which will measure the potential reduction in lung cancer mortality if HAP is eliminated or reduced
while adjusting for known and suspected lung carcinogens (i.e., ETS, OAP). Our robust harmonization of HAP data
will also provide the unique opportunity to determine the relative and absolute risks associated with HAP exposures
for cancers other than lung cancer, which was recently highlighted by an expert panel convened by multiple US
Federal Agencies.

Public health relevance
PROJECT NARRATIVE We are uniquely positioned to study pivotal questions relating to the adverse health effects of household air pollution (HAP), including (1) if biomass (i.e., wood) use is associated with lung cancer mortality, and (2) if HAP is associated with increased risk of cancers other than lung cancer. Using 13 cohort studies for a combined sample size of >550,000 subjects, we will be the first to prospectively evaluate cancer site-specific mortality and HAP. Our findings will inform policies and regulations designed to reduce the global burden of HAP-associated disease.